Harnessing nutrition to enhance vaccine responses

PROJECT ABSTRACT
Novel pathogens (e.g., SARS-CoV2, monkeypox, respiratory syncytial virus, and influenza) are constantly
emerging, creating an urgent, unmet need to identify strategies that enhance immunological memory. Our
previous work demonstrated that caloric restriction (CR) is a nutritional intervention that enhances immunological
memory in mice, resulting in 500-fold greater pathogen control (Collins N, Cell, 2019 and Han SJ…Collins N*,
PNAS, 2023). However, the molecular determinants, signaling pathways, and cell-cell interactions involved are
unknown. The objective of this proposal is to generate fundamental mechanistic information that fills these gaps
in knowledge, which will advance the field and ultimately reduce the burden of infectious diseases by (i)
revealing how CR can be utilized to enhance pathogen- and vaccine-elicited immunological memory, and (ii)
leading to the development of novel therapies that pharmacologically mimic the immune-enhancing effect of CR.
Our recent publication indicated that CR enhances immunity by increasing memory CD8+ T cell-derived IFN
and gut microbiota-derived acetate, which converge on myeloid cells to enhance their capacity to kill pathogens.
Our preliminary metabolomics data first show that CR potently modulates systemic nutrient abundance. Memory
CD8+ T cells metabolically adapt by switching their intracellular signaling pathways to promote the utilization of
nutrient sources that are abundant in this setting, as shown by preliminary single-cell RNA-seq and flow
cytometry results. The metabolic state adopted by memory T cells during CR has been shown to enhance their
function, providing a potential explanation for increased IFN production. A second essential effect of CR
demonstrated by metagenomics sequencing in our recent publication is a ~1000-fold enrichment of the
commensal Bifidobacteria that produce the short-chain fatty acid acetate. Ex vivo data indicates that the
combination of IFN and acetate is essential to enhance the ability of myeloid cells from mice on CR to kill
pathogens. Further, our RNA-seq identified that myeloid cells upregulate multiple genes related to pathogen
killing in vivo during CR. This proposal builds on our recent publication and extensive preliminary data and will
test the central hypothesis that CR induces memory CD8+ T cell metabolic rewiring to enhance the production
of IFN, which combines with Bifidobacteria-derived acetate to increase the capacity of myeloid cells to kill
pathogens. Based on our new data, this proposal will determine if (i) CR-induced metabolic reprogramming is
essential to enhance memory T cell IFN production, and (ii) how the combination of memory T cell-derived IFN
and microbiota-derived acetate enhances myeloid cells in this context. Altogether, we will define how CR
enhances and promotes cooperation between distinct immune cells for increased pathogen control. This will be
essential to achieving our long-term goal of reducing the burden of infectious disease by optimizing
immunological memory.

Public health relevance
PROJECT NARRATIVE Nutrition impacts all physiological processes, including those that regulate the development and function of the immune system. Caloric restriction is a nutritional intervention that enhances immune responses. The focus of this proposal is to mechanistically interrogate how caloric restriction optimizes immunological memory to ultimately harness this information in the design of novel and more effective vaccination strategies.